Dissecting the gut-hypothalamus axis for fructose sensing

PROJECT SUMMARY
Highly processed foods have become increasingly prevalent in our diets over the past several decades. These
foods often contain high levels of high fructose corn syrup (HFCS), and excess intake of HFCS is associated
with obesity and a host of associated metabolic diseases, such as type II diabetes and cardiovascular disease.
However, the gut-brain mechanisms through which fructose is sensed, and how it influences homeostatic feeding
circuits in the brain, are largely unknown. My preliminary data suggest that fructose engages the vagus nerve to
inhibit activity in hunger-promoting agouti-related protein (AgRP)-expressing neurons in the brain. Building on
this finding, this proposal will test the hypothesis that Y2-expressing vagal afferents sense fructose in the gut
and are sufficient and necessary for gut fructose-induced inhibition of AgRP neuron activity. Aim 1 will use single-
cell resolution two-photon calcium imaging to determine the real-time activity dynamics of fructose-activated
vagal afferents. In a complementary experiment, we will combine retrograde tracing to label gut-innervating vagal
afferents, with activity-dependent gene labeling via in situ hybridization in mice, to determine the molecular
identity of gut-innervating fructose-activated vagal afferents. Aim 2 will leverage an activity-dependent technique
to gain genetic access to fructose-responsive neurons to determine their role in modulating AgRP neuron activity
Through these experiments, we expect to reveal the gut-hypothalamic nutrient sensing pathway for fructose.
These results will not only provide new insight for the field of gut-brain signaling, but will also have clinical
applications by uncovering new potential drug targets for obesity treatment. My Sponsor, Dr. Amber Alhadeff, is
an expert in the gut-to-AgRP neural pathways involved in nutrient sensing, and my Co-sponsor, Dr. Guillaume
de Lartigue, has extensive experience with anatomical tracing and two-photon microscopy of vagal afferents. My
prior research experience, combined with the expertise of both Sponsors, make me uniquely positioned to
successfully complete all proposed experiments during my graduate training. Therefore, funding of this NRSA
proposal to support my dissertation studies will set me on the trajectory toward my ultimate goal of becoming an
independent investigator that explores gut-brain circuits that regulate feeding.

Public health relevance
PROJECT NARRATIVE The overconsumption of sugar, in particular fructose, leads to adverse metabolic consequences and obesity, but the mechanisms for gut-brain fructose sensing are unknown. This proposal will examine and characterize a vagal mechanism for gut-brain fructose sensing and will determine the gut-brain pathway that mediates fructose effects on hypothalamic neurons that drive feeding behavior.